In vivo mechanisms of Mycobacterium tuberculosis control and susceptibility

Project Summary
Mycobacterium tuberculosis (Mtb) infects the lungs causing 1.6 million deaths a year. The only vaccine
approved for tuberculosis has limited efficacy. Additionally, antibiotic treatment requires six months, but can
require two or more years for multi-drug resistant strains that are becoming more prevalent. Therefore,
development of a host-directed therapeutic strategy that directly targets the Mtb reservoir would dramatically
impact human health. I propose to identify novel innate immune factors that protect against Mtb infection in
vivo, which could be the basis of such a therapeutic approach. Specific Aims: During Mtb infection,
inflammatory cytokines like IL-1 stimulate non-infected cells to produce factors that enhance anti-bacterial
activity of Mtb-bearing cells. While IL-1 is critical for protection against Mtb, its mechanism of action is
unknown. Aim 1) We have identified IL-1 sensing cells in Mtb-infected lungs and IL-1-induced genes
expressed by these cells. I will test whether natural killer T 17 cells, one of the IL-1 sensing populations,
provides protection against Mtb. Additionally, I will determine which IL-1-induced genes act directly on Mtb
infected macrophages in vivo to confer the protective effect of IL-1. Aim 2) Neutrophils are detrimental in Mtb-
susceptible mouse strains and neutrophilia positively correlates with bacterial burden and mortality in humans.
However, it is unclear how neutrophils interfere with the host response to Mtb. We have previously shown that
IL-1 receptor antagonist (IL-1Ra) is an immunosuppressive molecule that limits Mtb control in a susceptible
mouse strain. As IL-1Ra is highly expressed by neutrophils, I will determine whether neutrophils inhibit the
protective response against Mtb through their production of IL-1Ra and whether this immunosuppressive
function is conserved across multiple Mtb susceptible strains. Additionally, I will determine whether neutrophils
exploit other immunosuppressive pathways, like IL-18 signaling inhibition and PD-1, to hinder the productive
immune response to Mtb. Study Design: I will define how communication between non-infected and infected
cells leads to control of tuberculosis infection by generating mixed bone marrow chimeras. These experiments
will test the in vivo relevance of IL-1-driven gene expression for candidates identified in our single cell RNA-
sequencing dataset of Mtb-infected lungs. Additionally, I will leverage our single cell RNA-sequencing dataset
to determine how neutrophils inhibit control of the infection in Mtb-sensitive mouse strains. Potential Impact:
The identification of protective and inhibitory regulators of Mtb control can serve as the basis for host-directed
therapies to treat Mtb infection, which will be a major advance for the field.

Public health relevance
Project Narrative This project seeks to identify novel positive and negative regulators of protection against Mycobacterium tuberculosis, the single deadliest pathogen in the world. Leveraging exciting preliminary data of Mtb-infected lungs analyzed by single cell RNA-sequencing, this project will identify pathways used by macrophages to restrict tuberculosis growth, as well as identify the mechanism by which neutrophils inhibit productive responses against this infection. Discovering new immune regulators of tuberculosis control will provide targets for host-directed therapies, which are in dire need due to lack of an efficacy vaccine and extremely long antibiotic treatment course for tuberculosis.